Driving Biomedical Projects

Driving Biomedical Projects
Abstract
The National Resource for Translational and Developmental Proteomics (NRTDP) will collaborate with
geographically diverse investigators to complete eight Driving Biomedical Projects (DBPs) seeking advances
that require top-down proteomics in four pillars of biomedical research. While these projects arise from disparate
areas of science and medicine, each project cannot be performed optimally with the technology available at this
point in time. These projects drive the Technology Research and Development (TR&D) projects of the
NRTDP forward – giving them a tangible and quantifiable goal with the overarching goal to impact and improve
human health. Our TR&D projects focus on specific technologies throughout the progression of each DBP from
accelerating top-down robustness to innovating novel targeted and discovery approaches from specific cell
types. Integrating parts of each TR&D project, we have arranged our eight DBPs around four pillars (described
in detail in the Overall section):
Specific Aim 1 (Pillar 1): Cancer Proteomics. Top-down proteomics of p53, RAS, and H3.3K27M.
Specific Aim 2 (Pillar 2): Immunoproteomics. Top-down analysis of multi-drug resistant ESKAPE pathogens
and identification of transplant rejection markers using quantitative top-down proteomics.
Specific Aim 3 (Pillar 3): Neuroproteomics. A specific focus on brain cancer and proteinopathies with roles in
neurodegeneration and aging.
Specific Aim 4 (Pillar 4): Cardiac Proteomics. Identifying the repertoire of ApoC-III proteoforms associated
with coronary artery disease.
It is through the integrated development of next generation proteomics technologies that we will be able to
achieve success in Driving Biomedical Projects within these four pillars. As these projects progress
throughout the lifetime of the grant, they will be reassessed and once technologies are matured, may be
translated into Collaboration and Service projects, allowing new biomedical problems to drive the next
generation of technology.